Cholesterol Regulation Through Retriever-Dependent LDL Receptor Recycling

PROJECT SUMMARY
Elevated plasma LDL cholesterol is a potent risk factor for atherosclerosis and cardiovascular
complications. LDL is cleared from circulation by LDL receptors (LDLR). Importantly, the balance
between internalization, recycling, and intracellular degradation of LDLR is critical in determining surface
expression of LDLR, LDL clearance, and plasma LDL concentrations. A pivotal regulator of endosomal
recycling of LDLR is the trimeric protein complex known as Retriever. Comprised of VPS35L, VPS26C,
and VPS29, Retriever is essential for identifying cargo proteins in the endosomal compartment to initiate
their recycling to the plasma membrane (PM). Over the past year, our multi-PI group leading this
application has published the first high-resolution structural model of Retriever using cryogenic electron
microscopy (cryo-EM), revealing unique features of this complex. Recycling of LDLR and other cargoes
requires Retriever binding with several crucial ligands, including sorting nexin SNX17, the
COMMD/CCDC22/CCDC93 (CCC) complex, and the WASH complex. Mutations in Retriever, CCC and
WASH complex subunits are associated with hypercholesterolemia in humans. However, the molecular
mechanisms linking Retriever to CCC and WASH complexes remain incompletely understood,
representing a major knowledge gap in the field, hindering our mechanistic understanding of how
Retriever regulates cholesterol homeostasis. Our hypothesis is that by using structural insights to
precisely uncouple Retriever from these critical ligands, we can achieve a comprehensive understanding
of their functional contributions to endosomal recycling and cholesterol homeostasis. Our team will
combine expertise in biochemistry, structural biology, cell biology, and animal models to obtain a detailed
molecular understanding of Retriever function through 3 aims: (1) Structural and biochemical analysis of
Retriever binding with key ligands, (2) Functional characterization of Retriever-ligand interactions in cargo
recycling using cell models, and, (3) Studies on the physiological significance of Retriever-ligand
interactions in cholesterol homeostasis using in vivo models of Retriever deficiency. Altogether,
completion of this work will greatly advance our mechanistic understanding of Retriever, a critical
regulator of endosomal protein recycling. Furthermore, by taking advantage of our unique structural,
biochemical, cellular, and animal model approaches, we will identify molecular pathways regulated by
Retriever-dependent recycling that play meaningful roles in determining circulating LDL levels. These
studies are of high relevance to cardiovascular health and the mission of NHLBI.

Public health relevance
PROJECT NARRATIVE Plasma cholesterol is a major determinant of cardiovascular health, as elevated LDL cholesterol promotes atherosclerosis and its numerous cardiovascular complications. LDL levels are determined by many factors, and among them, the density of LDL receptors in the plasma membrane of hepatocytes is of paramount importance. This project will explore a key pathway that controls LDL receptor recycling in the cells, whereby internalized LDLR receptors can be recycled back to the plasma membrane. This pathway, mediated by the Retriever complex, will be examined in great detail including molecular mechanisms and physiologic impact in animal models.